CReATE Motion Center: Cartilage Regeneration using Advanced Technologies to Enable Motion

This proposal will establish a new Center at the Corporal Michael J. Crescenz VA Medical Center (CMCVAMC)
in Philadelphia focused on Cartilage Regeneration using Advanced Technologies to Enable Motion
(CReATE Motion). This new initiative builds upon the extensive scientific foundation, outstanding infrastructure,
and thriving educational and mentoring programs that we have established within the musculoskeletal programs
at the CMCVAMC in the Translational Musculoskeletal Research Center (TMRC) and through our collaborations
with the Atlanta VA Medical Center (AVAMC). The CReATE Motion Center will include investigators with
expertise in musculoskeletal regeneration, pain, cell-based therapies, biomanufacturing, and translational
sciences drawn from Orthopaedic Surgery, Neurosurgery, the Department of Medicine, Bioengineering, and
Physical Medicine & Rehabilitation at the CMC VAMC and the University of Pennsylvania (its primary affiliate)
and the Atlanta VAMC and Emory University (its primary affiliate).
The Mission of our CReATE Motion Center is to develop a translational pipeline for advanced cartilage and
joint regenerative therapies aimed at treating arthritis, joint injuries, and related joint disorders, by cultivating
core infrastructure and building an intellectual critical mass in this area. We will apply this framework to
accelerate the clinical implementation of cutting-edge strategies to restore joint function and transform the
long-term health of our Veterans.
Our new CReATE Motion Center is focused on 3 major interacting research cores (RCs) that support 3 central
research focus areas (RFAs) and our educational and outreach mission. The Research Cores will focus on
Biomanufacturing and Translation (RC1), Rehabilitative Models and Tools (RC2), and Advancing Clinical
Evaluation (RC3). These Cores support the three main CReATE Motion Research Focus Areas, centered on
Molecules and Delivery Systems (RFA1), Cells and Cell Products (RFA2), and Biologic Joint Resurfacing’
(RFA3). CReATE Motion will fund Pilot Awards and Collaborative Exchanges in each of the 3 research focus
areas through a peer-reviewed mechanism. Taken Together, CReATE Motion, with its associated Cores,
Trainee, and Pilot Funding, is designed to produce new knowledge, novel products, and advances in clinical
care, with a specific focus on functional restoration of the musculoskeletal system.
Equally important to advancing the scientific and translational underpinnings of CReATE Motion is the training
of the next generation of VA-focused scientists and clinicians working in this research space and engaging
Veterans. To that end, our Educational and Outreach (E&O) mission includes (1) a Fellowship Program in
Translational Tissue Engineering & Regenerative Medicine (“T-TERM”) to educate trainees and the community
on processes of clinical translation and commercialization, (2) regular Techniques Workshops & Chalk Talks to
increase collaboration and interactions across the Center and utilization of Core resources, (3) a Seminar Series
focused on CReATE Motion related topics and translation, and most importantly (4) a focus on Patient Education,
Outreach, and Engagement to bring technologies and information to the Veterans that we serve.
If successful, this new CReATE Motion Center will establish a critical mass of expertise, a culture of innovation,
and cutting-edge infrastructure that will establish a nation-wide VA-based pipeline to move next-generation
regenerative therapies for cartilage restoration, repair and replacement from the laboratory to the clinic.

Public health relevance
Musculoskeletal diseases are the most common and disabling of conditions for Veterans. More than 1 in 3 suffer from osteoarthritis, the most common cause of disability and pain and termination of service. Our CReATE Motion Center will directly address this clinical need, across the spectrum of disease, by fostering a critical mass of expertise and a culture of innovation at the CMC VAMC in Philadelphia and the Atlanta VAMC. We will build on our cutting-edge infrastructure, extensive scientific foundation, and culture of mentoring and collaboration to establish a VA-based pipeline to move next-generation regenerative therapies from the laboratory to the patients that need them. Our CReATE Motion Center will restore joint health and mobility to Veterans, fulfilling the promise of regenerative therapies in the 21st Century.